Effects of Smoking on the Rotator Cuff Tendon-Bone Enthesis

SUMMARY
Rotator cuff tendon tears account for more than 4.5 million physician visits and over 300,000 surgical repairs
annually in the US. The healing rates of the tendon-bone interface, i.e., enthesis, remain low, despite continual
improvements in fixation techniques. Moreover, pre-existing degeneration at the rotator cuff enthesis puts an
estimated 17 million Americans at increased risk for rotator cuff impairment and tearing. A growing body of
evidence indicates that cigarette smoking is an important risk factor. CDC data show that almost 13% of US
adults smoke cigarettes, yet South Carolina rates are even higher at nearly 18%, with high school youth smoking
cigarettes in SC at more than 3 times the US rate. Despite this significant impact, we still lack a fundamental
understanding of the effects of cigarette smoking on the mechanical properties of the enthesis and the
biomechanic mechanisms. Obstacles in formulating such understanding are partly attributed to (i) challenges in
creating a realistic smoke exposure environment using well-controlled animal studies and (ii) the difficulties in
characterizing the small-scale structural changes and correlating the structural changes with the deterioration of
mechanical properties. We propose to utilize our custom-built automatic smoking chamber that resembles
realistic cigarette smoking on a rat model, plus adopt an integrated experimental and computational approach to
systematically understand the structure-function relationship of rat supraspinatus tendon-humerus enthesis and
how it is impacted by cigarette smoking. The proposed studies will test the hypothesis that smoking directly
affects the structure of collagen fibers plus the mineral gradient and distributions at the enthesis, all of which we
further hypothesize will lead to deterioration of the enthesis by changing the microscopic deformation patterns.
The specific aims are (1) to characterize the impact of smoking on the mechanical properties of the rotator cuff
tendon-bone enthesis; (2) to delineate the changes from smoking on the multiphasic structures at the tendon-
bone enthesis; (3) to construct a multiscale modeling framework that bridges the structures with the mechanical
properties. We will integrate tissue biomechanics, bioimaging, and multiscale modeling to characterize the
structure-function relationship of the enthesis, provide novel mechanistic data that will inform rotator cuff injury
risk associated with cigarette smoking, and understand the underlying mechanisms. Once this approach is
successfully applied, the tools and insights from this project can be transferred to other soft tissue-bone
interfaces. Moreover, the new knowledge generated from this project, particularly the degenerative impact of
smoking on rotator cuff tendon-bone enthesis, will lay the foundation for innovating treatment strategies for
repairing the interfaces and improving the surgical outcomes of high-risk and/or rural area patients.

Public health relevance
NARRATIVE Rotator cuff tendon tears account for more than 4.5 million physician visits annually, and multiple risk factors can lead to pre-existing degenerations, putting an estimated 17 million Americans at increased risk for rotator cuff impairment and tearing. This proposal aims to understand how cigarette smoking, an important yet complicated risk factor for rotator cuff injuries, influences the structures within the tendon-bone interface and their biomechanics. A computational modeling framework will be developed to more fully understand the mechanisms of the degenerative effects of smoking on the rotator cuff tendon-bone interface and as a foundation for future work on developing better therapeutics and surgical approaches for repairing the interface.